Neurologic Oncology Program

Neurologic Oncology Program: Summary
The overarching scientific goal of the Neurologic Oncology (NE) Program is to use a team approach to
advance the understanding of brain tumor biology and drive translation into more effective treatments. This
goal is accomplished by innovative basic science, accompanied by a classic bench-to-bedside approach,
which allows basic science discoveries to be developed into therapies and clinical trials. Further basic science
exploration is also informed by insights that come from clinical care of the patient, previous clinical trial results,
exceptional drug responders, and patients who develop resistance to treatment.
Theme 1: Improved Understanding of the Underlying Biology of Brain Tumors
Theme 2: Predicting Patient Disease, Response, and Survival
Theme 3: Improving the Therapy of Brain Tumors
NE Program: Key Metrics
Membership (7 departments, 1 school) 31
Full 19
Associate 12
Cancer-relevant Funding (direct costs as of
$8,749,672
05/31/2017)
NCI $4,023,515 46%
Peer-reviewed $1,511,567 17%
Non-peer-reviewed $3,214,590 37%
Cancer-relevant Publications (1/2012-7/2017) 553
Inter-programmatic 263 48%
Intra-Programmatic 260 47%
High-Impact 109 20%
Accruals to Clinical Trials (2016) 254 40
Therapeutic 56 25
Other Interventional 54 5
Non-interventional 144 10